Mechanisms of Early Functional Loss in Diabetic Eye Disease

PROJECT SUMMARY
Although there is growing consensus that diabetic retinal neurodegeneration (DRN) can
precede clinically-apparent vascular abnormalities and may eventually be useful for staging
diabetic retinopathy (DR), there is no agreement regarding how DRN is defined, staged, or
which measures best reflect neural dysfunction in these individuals. Work completed during
prior funding cycles, supported by other researchers, has shown that electrophysiological,
psychophysical, and pupillometric approaches can provide sensitive, non-invasive, and
quantifiable measures of DRN. However, prior studies that have measured functional
consequences of DRN have generally been cross-sectional and performed under typical light-
adapted clinical conditions. These studies provide little insight into important challenges
reported by individuals with DR, including functioning under dim illumination and adjusting to
changing illumination conditions. To address these limitations, we propose to develop and apply
novel tools and approaches capable of characterizing the nature and extent of visual
dysfunction and its relationship to DRN in individuals with mild or no DR (M/N DR). These
approaches will evaluate visual function across a wide range of lighting conditions typical of
daily life, assess the ability to adjust to changing illumination conditions, and will be performed
longitudinally. Three complementary aims are proposed that use non-invasive tools to provide
new views of retinal function under broad and varying levels of illumination: Aim 1 will define key
pathophysiological changes in rod, cone, and post-receptor function in M/N DR; Aim 2 will
develop and apply a battery of electrophysiological techniques to identify photoreceptor and
downstream post-receptor dysfunction; Aim 3 will determine how M/N DR affects non-image-
forming pathways. We will determine whether functional measures targeting the inner- or outer-
retina show greater DRN progression and if either predicts ETDRS stage advancement.
Completing these Aims will: 1) provide a novel framework using complementary approaches for
assessing visual dysfunction and the underlying mechanisms in M/N DR, 2) introduce new tools
and functional assays that can provide clinically-relevant indices of DRN that address common
visual complaints of DR subjects, 3) permit comparisons among measures to define optimal
tests of DRN with high diagnostic power. We expect these studies to drive significant advances
in clinical DR staging and understanding of early neural deficits.

Public health relevance
PROJECT NARRATIVE This study will identify mechanisms underlying deficits in visual function in diabetic patients who have not yet developed clinically-apparent retinopathy or who are in the earliest stages of the disease. This research addresses the need for improved testing strategies with enhanced sensitivity for evaluating the progression of diabetic eye disease, subtyping patients who do not have vascular abnormalities for inclusion in treatment trials, and for assessing the outcomes of therapeutic interventions. Novel tests with enhanced sensitivity are urgently needed as therapies that target early-stage diabetic retinopathy begin to enter clinical trials.